Role of Screening and Early Intervention in Primary Care with Low-Dose Pioglitazone for Patients with T2DM and NASH

Project Abstract/Summary
Nonalcoholic steatohepatitis (NASH) is known to occur often in type 2 diabetes mellitus (T2DM). Hepatologists
know this firsthand from their clinical experience as well as from many cross-sectional studies, where T2DM is
common among patients with cirrhosis or HCC. However, this knowledge has not trickled down to primary care
physicians (PCPs) or translated into a systematic screening of patients with T2DM. Most PCPs simply remain
largely unaware about the health risks associated with NASH and have limited information about the epidemic
of NASH in the primary care setting, therefore, not finding a reason why to screen or treat. New studies have led
to a consensus among hepatologists that patients with moderate fibrosis (≥F2) are on a disease path that leads
to cirrhosis or HCC, more cardiovascular disease and increased mortality. Unfortunately, most NASH patients
today are not diagnosed until it is too late. With evidence that a generic drug such as pioglitazone (PIO) leads to
resolution of NASH in ~60% of patients, this is a missed opportunity to save lives and resources. However, most
hepatologists are uncomfortable with prescribing PIO due to undesirable side effects (weight gain, lower
extremity edema, bone loss, bladder cancer?). However, since even low doses of PIO (15 mg/day) increases
adiponectin ~2-fold and improves adipose tissue insulin resistance, it is likely that a similar effect may be
achieved on hepatic “lipotoxicity” and liver histology with doses that have minimal side effects. However, this
hypothesis has never been tested before in a dose-response study in pts with NASH.
We propose to develop a novel strategy for patients with T2DM and NASH shifting the focus from a late
diagnosis and referral to hepatology, to an early diagnosis and intervention in the PCP clinics. First, to establish
the magnitude of the problem of moderate-to-advanced fibrosis (≥F2) within the PCP setting (Aim 1) we will
screen for NAFLD/liver fibrosis by CAP/VCTE (Fibroscan). Those with NASH-fibrosis will be offered treatment
with low-dose PIO (15 mg/day) or placebo (Aim 2; an intermediate-dose of 30 mg/day will be also used to
compare safety and efficacy, but interest is on the 15 mg/day dose). We will avoid the high 45 mg/day doses
used by our group for proof-of-concept studies but associated with long-term safety concerns and limited clinical
acceptance. In Aim 3, all patients with T2DM and NAFLD (not participating in Aim 2) will be followed for ~4 years
to establish the impact of NAFLD on diabetic complications (compared to diabetics without NAFLD). Recent
cross-sectional studies suggest that NAFLD carries a greater risk of micro- and macrovascular diabetic
complications. However, this has never been prospectively studied.
In summary, the above highly complementary studies will offer the first compelling evidence of the epidemic
of NASH-fibrosis within PCP clinics; test that NASH-fibrosis can be identified early-on in T2DM and treated
safely by PCPs with low-dose PIO, and the impact of NAFLD on diabetic complications.

Public health relevance
Project Narrative Nonalcoholic fatty liver disease (NAFLD) is common in type 2 diabetes mellitus (T2DM) and is often associated with liver inflammation and fibrosis that may lead to cirrhosis, even liver cancer. Most patients and primary care physicians are unaware about the health risks associated with NAFLD, therefore, not finding a reason why to screen or treat. This study proposes to assess with an ultrasound-type device (Fibroscan) how often severe liver disease is present in the primary care setting, propose to treat early-on with a medication (pioglitazone) known to improve its more severe form (NASH) but at lower and safer doses than those previously used, and also examine if having fatty liver disease is associated with worse diabetes complications.